BIOCHEMICAL GENETIC MONITORING OF INBRED RODENTS

Continue to provide high quality test rodents to the toxicology and carcinogenicity bioassay program. It will enhance the Program Resources Branch of the TRTP's ability to determine the genetic integrity of rodent production colonies as well as animals supplied by testing facilities.